Resolving epigenetic instability during pluripotent state transitions: a roadmap for exploiting the biomedical potential of dynamic human stem cell states

ABSTRACT
A major goal of stem cell research is to derive high-quality human pluripotent stem cells (hPSCs) that
possess the unique transcriptional, epigenetic, and functional properties of developmentally unrestricted
“naïve” pluripotent cells found in the pre-implantation blastocyst in vivo. In contrast, hPSCs derived under
traditional conditions represent a more advanced or “primed” developmental state that corresponds to the
late post-implantation epiblast. My work and that of others has shown that primed hPSCs can be
reprogrammed into a naïve state marked by globally reduced DNA methylation levels, X chromosome
reactivation in female cells, and a broad capacity for differentiation along extraembryonic fates. However,
the widespread utilization of naïve hPSCs in biomedical research is currently impaired by epigenetic
instability during establishment and maintenance of the naïve state. In particular, naïve hPSCs generated
with currently available methods display irreversible erasure of parent-specific imprinting, retain an
epigenetic memory of the inactive X chromosome in female cells, and are not directly responsive to lineage
cues for embryonic germ layer induction. My long-term goal is to design rational strategies to derive naïve
hPSCs that faithfully recapitulate pluripotent cells in vivo and establish a robust cellular platform for
modeling human development and disease. Based on our published and preliminary data, I
hypothesize that aberrant epigenetic reprogramming during induction of naïve pluripotency is a
consequence of inappropriate signal perturbation. I propose to enhance the epigenetic fidelity of naïve
hPSCs by pursuing three complementary research directions. The first is to elucidate the signaling cascade
during early stages of the primed-to-naïve transition using quantitative phosphoproteomics, as a basis for
developing strategies to activate the naïve transcriptional circuitry without inadvertently inducing genetic
or epigenetic instability. Second, I will employ recently established fluorescent reporter cell lines in
combination with chemical and genetic approaches to preserve parent-specific epigenetic information
during the establishment of naïve pluripotency and promote random XCI upon exit from naïve human
pluripotency. Third, I will enhance the competence of naïve hPSCs for rapid induction of all three embryonic
germ layers (endoderm, mesoderm, and ectoderm) by targeted epigenome editing of cis-regulatory
elements that gain accessibility during the transition from naïve to primed pluripotency. The overall aim of
this project is to exploit the presently untapped biomedical potential of naïve hPSCs and generate a robust
in vitro platform to model early human development and disease.

Public health relevance
PROJECT NARRATIVE The past decade has witnessed significant interest in the isolation of “naïve” human pluripotent stem cells that more closely resemble pluripotent cells found in the human blastocyst in vivo. However, naïve human pluripotent stem cells generated with currently available methods display irreversible erasure of parent- specific imprinting, retain an epigenetic memory of the inactive X chromosome in female cells, and are not directly responsive to embryonic lineage cues. This proposal will design rational strategies to resolve this epigenetic instability and establish a robust in vitro platform to model early human development and X- linked disorders.